Mechanistic understanding of role of ATF2 signaling in radiation-induced esophageal cancer

Project Summary/Abstract
The objectives of this proposal are to define fundamental mechanisms that drive radiation-induced esophageal
squamous cell carcinoma (ESCC). There is compelling evidence linking an increased risk of developing ESCC
with a history of therapeutic radiation exposure. Elucidating the machinery that drives tumor susceptibility, is of
major import to NCI, as ESCC is the deadliest of all human squamous cell carcinomas. Abnormalities in stress
signaling, in proteins such as ATF2 are strongly implicated in cancers. Additionally, a central role of epithelial to
mesenchymal transition (EMT) in the promotion of cancer has gained prominence. Knowledge of pathways that
translate radiation-induced aberrant signaling to changes in the microenvironment is lacking and essential to
assess cancer risk post radiation exposure. This is a major gap in the field, which the current project proposes
to bridge. Our preliminary studies suggest a strong association between persistent pATF2ser 490/98 signaling and
EMT, both events regulated by transforming growth factor  (TGF). Our main objectives are to understand the
role of TGFβ-mediated pATF2 signaling and its relationship to EMT, to provide insight into how changes in the
microenvironment allow radiation-induced tumor initiation and progression and identify biomarkers for ESCC
radiation-induced carcinogenesis. We hypothesize that TGF driven persistent pATF2 signaling triggers EMT
post radiation exposure, and this signaling network creates a tumor permissive microenvironment. To test this
hypothesis, we will use well-characterized normal and transformed cells containing genetic alterations commonly
occurring in esophageal cancer, and 3D cell culture systems, closely mimicking the in vivo physiological
environment of the esophagus. High and low dose fractionated radiation will be used to simulate the exposure
to the esophagus from radiotherapeutic cancer treatments. CRISPR technology will be used to mutate the ATF2
phospho-sites to define dependency of this signaling. Immunofluorescence, immunohistochemistry, and RNA
seq will be used to address the specific aims and gain a mechanistic understanding of these events. We will (1)
test our hypothesis that EMT induction is a consequence of fractionated radiation-induced aberrant pATF2
signaling, and (2) investigate the effect of pATF2 signaling on tissue architecture, promotion of a tumor
phenotype, and transcriptomics post radiation exposure. Our contribution is expected to provide an innovative
approach to understand how radiation, through its influence on intercellular communication and interactions with
the microenvironment affects levels of biological organization and promotes cancer. This proposal addresses
relevant scientific areas of emerging importance such as the contribution of persistent stress signaling, and
microenvironment changes in promoting carcinogenesis. These studies are especially significant, as elucidating
the underlying mechanisms that promote radiation-induced carcinogenesis could aid in predicting patients at an
increased risk of developing ESCC and give mechanistic insights into the radiation-related carcinogenesis of
other tumor types including esophageal adenocarcinoma (EAC).

Public health relevance
Project Narrative Esophageal squamous cell carcinoma (ESCC) is the deadliest of all human squamous cell carcinomas, and has a relatively low five-year survival rate. Abnormalities in stress response signaling and epithelial to mesenchymal transition (EMT) have gained prominence as cancer promoting mechanisms. These studies will define whether radiation-induced persistent pATF2 stress response signaling, is a key node in promoting EMT and changes in the microenvironment that facilitate radiation-induced ESCC initiation and/or progression.